ACUTE EFFECTS OF ALCOHOL AND ENERGY DRINKS ON BEHAVIORAL CONTROL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The working hypothesis of this proposal is that the consumption of AmED may be riskier than alcohol consumption alone. Mixing alcohol with another beverage with strong stimulant properties may decrease self[unreadable]perceptions of intoxication and may increase the reinforcing properties of alcohol. In addition, the acute effects of alcohol impair impulse control, and this impairment may not be counteracted by co-administration of a stimulant. The proposed research will examine the acute effects of alcohol, energy drinks, AmED or a placebo beverage in social drinkers. The effects of these beverages will be determined by performance on tasks that measure neurocognitive control mechanisms and the subjective effects of alcohol. The specific aims of the proposed research are: 1) to determine whether the consumption of AmED alters neurocognitive and subjective measures of intoxication compared to the consumption of alcohol alone, and 2) to establish whether the consumption of AmED enhances priming of the motivation to drink alcohol compared with the consumption of alcohol alone. The results of these studies should elucidate whether the consumption of AmED increases alcohol consumption and may be escalating binge drinking in young people.